Development of point-of-care testing for Lassa and other hemorrhagic fever arenaviruses

Project Summary/Abstract
Emerging infectious diseases pose a significant risk to human health. Among emerging pathogens,
hemorrhagic fever viruses (HFVs) pose the greatest risk in terms of the potential for morbidity and
mortality. These viruses are endemic in remote regions, produce large outbreaks that display high
mortality rates, and have a high potential become pandemics. One of the largest families of HFVs is the
Arenaviruses, which includes 6 DHHS select agents. The most well-known of these, Lassa virus, has
caused an increasing number of infections in recent years, including a 2018 outbreak in Nigeria that led
to over 100 deaths. In 2017, the World health Organization designated Lassa virus as a priority
pathogen for R&D efforts due to its potential to generate a public health emergency. Other hemorrhagic
fever arenaviruses, including Lujo, Chapare, Guanarito, Junin, and Machupo represent an increasing
source of concern based on their increased distribution and recent instances of human-to-human
transmission. Current diagnostic capabilities for Lassa virus and other arenaviruses are extremely
limited, especially in the case of point-of-care (POC) diagnostic assays. Here, we propose to develop a
POC diagnostic assay with the sensitivity and breadth of coverage required to diagnose Lassa virus
infections currently present in West Africa. In addition, we will generate single chain antibody phage
display libraries, broadly reactive high affinity diagnostic antibody pairs, a prototype assay chips for the 5
other arenaviruses that are Category A Priority Pathogens. We have previously used these procedures
to develop a POC diagnostic assay for Ebola virus that displays a sensitivity better than the current gold
standard, PCR. The successful completion of these studies will result in the first POC diagnostic assay
that is capable of detecting all Lassa strains of clinical importance and a panel of high affinity diagnostic
Abs and assays for all Category A Arenaviruses. In addition, the broadly reactive single chain antibody
libraries we produce could be used to rapidly generate diagnostic antibodies against novel arenaviruses
that arise as zoonotic outbreaks. This work will thus significantly improve our preparedness for almost
any future major Arenavirus outbreak with pandemic potential.

Public health relevance
Project Narrative Currently, a large number of Lassa virus and other arenavirus infections cannot be diagnosed because no existing point of care diagnostic assays can detect infection with the required level of sensitivity. The proposed studies will result in a panel of diagnostic antibodies that can detect all circulating Lassa virus strains, the first point-of-care assay for Lassa virus infection with the sensitivity to support case detection, surveillance, and outbreak response, and broadly reactive high affinity diagnostic antibody pairs the 5 other arenaviruses that are Category A Priority Pathogens. This will address a critical global health need by allowing the accurate diagnosis of Lassa fever in all settings, markedly improving the care and management of Lassa fever patients, and facilitating the timely control of all arenavirus outbreaks